EFFECT OF ORAL ESTROGEN ON SERUM CHOLESTEROL IN DIALYSIS PATIENTS

The purpose of this study is study how menopausal women absorb and metabolize an estrogen pill. We are interested in whether menopausal women who are on dialysis absorb and metabolize estrogen the same way as those with normal kidney function.